Incorporating a developmental perspective into gene identification models for alcohol outcomes

Project Summary
Frequent alcohol use can lead to alcohol use disorder, which accounts for three million deaths and over 133
million life years lost to disability and death worldwide per year. Alcohol use outcomes are under genetic
influence. Genome-wide association represents the state-of-the-science statistical methodology for identifying
genes associated with alcohol use outcomes. However, contemporary GWAS methods typically do not account
for variability in genetic effects throughout development. For example, when analyzing longitudinal data, most
contemporary GWAS are developmentally agnostic and average across timepoints to construct a phenotype
that disregards developmental variability in genetic effects. GWAS summary statistics are used as the starting
point for phenotype prediction via polygenic risk scores (PRS), which aggregate measured genetic effects on a
phenotype into a score that indexes the statistical association between SNPs and the phenotype. Models of
genetic influences on alcohol use might be improved if they consider the phenotype as dynamic over time,
rather than a fixed maximum or average. No previous studies have constructed PRS from developmentally-
informative GWAS, that measure genetic effects that are specific to developmental stage and change over
time. In this project, I will apply novel multivariate genomic methods to incorporate developmentally-informative
phenotype data into GWAS, create PRS that reflect change over time in alcohol use and PRS that are specific
to developmental stage, and validate findings in an independent sample. Longitudinal cohort studies targeted
for gene-identification analyses include the Avon Longitudinal Study of Parents and Children (ALSPAC,
n~10,000), the Collaborative Study on the Genetics of Alcoholism (COGA, n~2,000), and The National
Longitudinal Study of Adolescent to Adult Health (Add Health, n~6,000). Genetic prediction analyses will be
conducted in the Finnish Twin Cohort Study (Finn Twin, n~1,400). This project is consistent with NIAAA’s goal
to take a lifespan approach to alcohol use and disorder, and provides an analytical approach for doing this for
alcohol gene identification efforts. These novel methods will advance the field of behavior genetics beyond the
study of aggregated longitudinal phenotypes and represents an important step towards the broader NIH goal of
advancing precision medicine strategies for alcohol use outcomes.

Public health relevance
Project Narrative Studies that aim to identify genes associated with alcohol use outcomes in longitudinal datasets often average across timepoints or examine lifetime measures, constructing phenotypes that disregard developmental variability in genetic effects. Predictive models of genetic influences on alcohol use may be improved if they measure genetic effects that are unique to different developmental periods and, subsequently, leverage these unique effects for the prediction of alcohol use outcomes throughout the lifespan. The proposed research will implement novel methods to conduct a longitudinal gene-identification study of alcohol use and use the resulting genetic effects to predict alcohol use throughout the lifespan in an independent sample.